Computational and electrochemical substrates of social decision-making in humans

SUMMARY
Dopamine and serotonin systems in the human brain represent two key neuromodulatory signalling systems that
impact mood, value-based decision-making, learning, and a host of other cognitive functions. Despite their
importance, there is no consensus view from a psychological or computational perspective concerning their
exact information-processing functions. Consequently, there is a scarceness of strategies to treat disorders that
afflict these systems. We believe that this gap exists primarily because of methodological limitations. While there
are many fast methods for recording action potential activity and local field potentials, similar progress for tracking
`the other end of the problem' - neurochemical dynamics - has lagged far behind. This is unfortunate since just
considering the catecholamines dopamine, serotonin, and norepinephrine, the worldwide health burden of
dysfunction in these neuromodulatory systems is immense approaching 400 million people worldwide if one
includes just Major Depression and Attention-deficit hyperactivity disorders (WHO, 2017).
The overall goal of this project is to investigate the computational and neuromodulatory substrates of interactive
social processes hypothesized to be trans-diagnostic RDoC constructs. We will utilize two levels of analysis
(molecules/circuits and behavioral/computational) across two RDoC constructs (systems for social
processes: perception and understanding of others, subconstruct understanding mental states, and positive
valence systems: reward learning, subconstruct reward prediction error) to make inroads into understanding
the computational and neural underpinnings of social interaction in humans. Crucially, the interactive social
tasks used in this proposal generate an important class of learning signal – a reward prediction error signal –
but expressed in the context of an inter-personal interaction. Our two levels of analysis employ (1) computational
models of human (two-agent) social exchange estimated from detailed, observed behavior and (2) unique sub-
second measurements of dopamine and serotonin from human striatum (three separate sites: caudate, putamen,
ventral striatum) during the window-of-opportunity afforded by deep brain stimulating (DBS) electrode
implantation surgery for Parkinson's Disease, Essential Tremors, Obsessive Compulsive Disorder.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) Dopamine and serotonin jointly influence a broad range of healthy cognition and changes in their delivery or action are thought to underpin a variety of pathological conditions including major depressive disorder, drug addiction, attention-deficit-hyperactivity disorder, and Parkinson's Disease. During the window-of-opportunity afforded by deep brain stimulating (DBS) electrode implantation, we will make the first recordings of joint dopamine and serotonin dynamics in the striatum of conscious humans during the execution of inter-personal social exchange games. This work will address for the first time how these important neuromodulators encode social processes important for healthy cognition and affected by disease and injury.